Erythropoietin and trained immunity intransplantation

Summary
Transplantation
T
critical Macrophages are constantly exposed to damage- and pathogen-associated
molecular patterns (DAMPs and PAMPs). These stimuli directly induce the release of proinflammatory
molecules, but they also promote epigenetic and metabolic modifications, leading to a long-lasting increase in
macrophage functional responsiveness (trained immunity). The identification of therapies to target trained
immunity is an unmet need in transplant medicine.
is the ideal treatment f or end-stage organ failure, but long-term graft survival is still insufficient.
and B cells have a key role in acute rejection, but recent evidence indicates that also innate immune cells are
in alloimmune response.
This
erythropoietin
grant renewal builds logically on the results generated during the first funding cycle showing that
(EPO)has immunomodulating activity in murine and human cells. We showed that EPO promotes
conversion of naïve T cells into regulatory T cells (Treg) in mice and humans, leading to prolonged graft survival
and reduced severity of multiple autoimmune disease models in mice. Our new preliminary data indicate that
EPO has also inhibitory effects on macrophage training and hinders the proinflammatory program of previously
trained cells. This effect, that occurs through a direct interaction with the EPO receptor on myeloid cells, leads
to prolonged graft survival in mice that underwent training. The present proposal will address the mechanisms
responsible for these effects using in vivo and in vitro systems. We will also test the role of endogenous EPO on
trained immunity.
The results of this research project will provide new insight on the role of macrophage training in alloimmune
responses and how EPO counteracts them. The data have the potential to unravel cellular and molecular
pathways that are important in the pathophysiology of rejection and to identify new therapeutic targets. The fact
that EPO is FDA-approved, makes our findings easier to be translated into the clinic.

Public health relevance
Project Narrative These studies seek to identify the role of erythropoietin (EPO) in macrophage training during alloimmune response taking advantage of conditional KO mice. The experiments will employ: i) mouse models of heart transplantation with prolonged cold ischemia storage, ii) life-sustaining kidney transplant models (showing pathological features similar to those found in human transplant recipients), and iii) previously stored samples from kidney transplant recipients treated with EPO. The proposed mechanistic studies will improve our understanding of alloimmunity and will identify therapeutic targets to improve outcomes of transplant recipients.